Realistic models of gastrointestinal bioelectromagnetism

DESCRIPTION (provided by applicant): As reductionist biomedical science succeeds in elucidating ever more detail at the molecular level, a mathematical modeling framework will become increasingly important to cope with this explosion of data and to relate integrated whole organ function to underlying biophysically detailed mechanisms that exploit this molecular knowledge. The proposed research has two primary long term objectives. The first is to develop an extensible anatomically and biophysically based modeling framework that can be used to integrate the physiological, anatomical and medical knowledge of the gastrointestinal (GI) system. The second objective is to focus this integrative modeling framework on two major diseases of the GI tract which affect a significant number of people in the United States, namely intestinal ischemia and diabetic gastroparesis. Prior research has shown that recordings of the magnetic field from gastrointestinal electrical activity using multichannel Superconducting QUantum Interference Device (SQUID) magnetometers provides a noninvasive, noncontact assessment of the physiological state of the GI smooth muscle. We will combine multichannel SQUID and cutaneous electrode measurements with anatomically based integrative computer models to investigate the inter- and intra-subject effects of intestinal ischemia and gastroparesis on GI electrical activity noninvasively. We hypothesize that the resulting integration of anatomical and physiological biophysical properties will serve as a basis for a more complete understanding of the gastrointestinal system and will aid in the detection and diagnosis and ultimately, in the treatment of gastrointestinal disorders. This is necessarily a collaborative project that initially involves four groups (the Living State Physics Group at Vanderbilt University, The Department of Surgery at Vanderbilt University, the Department of Physiology and Cell Biology, University of Nevada School of Medicine and the Bioengineering Institute at The University of Auckland) and combines expertise in integrated biophysically based modeling with physiological, clinical and research expertise in the function of the gastrointestinal system.